Utilizing Technology and AI Approaches to Facilitate Independence and Resilience in Older Adults

The overarching goal of this application is to build an Artificial Intelligence (AI)
and Technology Collaboratory (AITC) ecosystem that will serve as a national resource to promote
the development and implementation of novel AI and technology approaches to improve care and
health outcomes for older Americans. The specific aims are: 1) To engage AI and
geriatric/gerontology investigators from across the country and to identify, validate, test, and
develop new AI and technologies relevant to improving the health and wellbeing
of older adults through crucial pilot study mechanisms; 2) To serve as a national resource center
that stimulates and leads the development and implementation of effective
novel AI and technology approaches and products that will promote the health, wellbeing
and independence of all older Americans; 3) To support the engagement of stakeholders
in AI research; 4) To build an ecosystem of overlapping innovation and business, academic, and
communities- of-practice networks ; and 5) To provide highest quality expertise, support, and
infrastructure needed to disseminate technical and policy guidelines and best practices for
effectively incorporating AI approaches and technology for older Americans, in partnership with
private industry, angel investors, venture capital firms, and healthcare systems. This AITC is
directed by a multi-PI interdisciplinary team led by two world-class experienced investigators who
have long worked successfully in the fields of AI and technology development areas partnered
with investigators who have long and successfully worked at the translational interface that
connects real-world medical, cognitive, and functional declines that impact older adults with
medical and technological solutions. Each of these investigators has a complementary skill set
and a long track records of organizing transdisciplinary teams and consortiums of investigators
around core themes. This interdisciplinary, accomplished, and highly visible leadership team will
work together to develop vision for the next generation of AI in aging science and to build a
scientifically and culturally diverse community of AI scholars and trainees around Aging. To
achieve our goals, we designed the JHU AITC to have robust scientific and technological
expertise that are described in eight core components. This infrastructure will support the
implementation of stakeholder input and the identification of relevant technologies and
investigators locally and nationally through a vetting and feasibility testing process of
both technology and data processes. It will include a pilot testing phase and related oversight
process. We have also established a key partnership with the Iowa office of Rural Health and
Veterans Rural Health Resource Centers Leadership and with organizations within Johns Hopkins
University that focus on improvements in the health and well-being of older adults in underserved
urban communities. Connections with key academic, industry partners have also been
established to accelerate the development of relevant technologies into products. This team is
dedicated to developing the next AI scientific advances and disseminating resulting strategies into
practice and policy that will maximize health, well-being, and independence for older adults.

Public health relevance
As the number of older adults increases, many older adults live with conditions that profoundly impact their health, well-being, and ability to maintain independence. Artificial Intelligence offers an unprecedented opportunity to mitigate the impact of aging, to arm health care providers with new tools and to empower older adults including those with Alzheimer’s Dementia and their caregivers. The Johns Hopkins AI and Technology Collaboratory ecosystem will serve as a national resource to promote and guide the development and implementation of novel AI and technology approaches to improve care and health outcomes for older Americans.